Mechanism of CX3CR1+ macrophage-mediated resolution of eosinophilic allergic lung inflammation

Title: Mechanism of CX3CR1+ macrophage-mediated resolution of eosinophilic allergic lung inflammation
Abstract:
Recent studies show that tissue-resident macrophages participate in not only the initiation of inflammation but
also in the resolution and prevention of local inflammation. To precisely determine the subsets of macrophages
engaged in resolving lung inflammation and gain insight into their functions, we adopted new techniques of
mass cytometry and single-cell RNA-seq (sc-RNA-seq) to analyze human and mouse macrophages in the
lung. Our supporting data showed that alveolar macrophages (AMs) are phenotypically diverse and highly
dynamic in response to allergen challenge. Based on the sc-RNA-seq data, AMs can be clustered into a few
groups at a steady status. Among these groups, a subset of CX3CR1-expressing AMs (CX3CR1+ AMs) are
unique in terms of their phenotype and patterns of gene expression, compared to classical resident AMs which
are CX3CR1 negative. In patients with allergic asthma and a mouse model of asthma, we found that CX3CR1+
AMs are markedly increased in BAL by allergen challenge. The CX3CR1+ AMs express not only the
macrophage but also eosinophil markers such as human Siglec-8. Further investigation with the CX3CR1-
reporter and Epx-cre (a.k.a. Eo-cre) reporter mice reveals that CX3CR1+ macrophages engulf eosinophils at a
steady state and in allergic lung inflammation. Depletion of CX3CR1+ macrophages in mouse models resulted
in spontaneous tissue eosinophilia at a steady status and prolonged tissue eosinophilia in allergic lung
inflammation. Based on this data, we hypothesized that the newly recruited CX3CR1+ AM subset promote the
clearance of tissue eosinophils and facilitates the resolution of allergic lung inflammation. In aim 1, we will
focus on the cellular dynamics of CX3CR1+ macrophages in allergic lung inflammation. Regarding the
molecular mechanism of CX3CR1+ mediated-eosinophil clearance, we examined the potential ligands for
CX3CR1 – CX3CL1 and CCL26. We discovered that CCL26 plays a key role in activating CX3CR1+
macrophages, whereas CX3CL1 is indispensable. Our sc-RNA-seq data revealed that CX3CR1+ AM subset is
the sole source of the transcript of C1q - a key molecule for efferocytosis. In in-vitro setting, CCL26 triggers
CX3CR1+ macrophages to secrete C1q in a CX3CR1 receptor-mediated manner. Furthermore, C1q and CCL26
are increased in BAL by allergen challenge in patients with allergic asthma. This data suggests CCL26
activates CX3CR1+ macrophages to facilitate efferocytosis via C1q secretion. In aim 2, we will examine the
detailed mechanisms of CX3CR1+ macrophage activation through CCL26-mediated C1q secretion. Finally, we
will extend the study to translational human research using the IRB-approved protocol for the segmental
provocation with an allergen to evaluate the human relevance of the above proposed experiments. The
proposed study is based on our strong supporting data on the new roles of CX3CR1+ macrophages in the
resolution of allergic lung inflammation. This study will lead to a better understanding of the resolution process
of allergic asthma.

Public health relevance
Asthma is a major health care burden to patients, families, and societies. The management of asthma is far less than ideal, in part due to our incomplete understanding of cellular and molecular processes of asthmatic inflammation. This proposal seeks to determine the novel mechanism of the resolution of allergic inflammation, specifically focusing on a specialized cell type that is responsible for clearing inflammatory cells and their debris to facilitate the resolution of inflammation. The proposed study would lead to a better understanding of pathogenesis of asthma, eventually improving the management of asthma.